Endowment for Cardiometabolic Health Disparities Research

PROJECT SUMMARY or ABSTRACT
The long-term objective of the Endowment for Cardiometabolic Health Research is to expand the capacity of Meharry Medical College (MMC) to enhance research and research training in cardiometabolic health. The program will address health outcomes in cardiometabolic health disproportionately prevalent in the United States citizens of Nashville and Davidson County, the catchment areas of MMC. We will accomplish this objective by recruiting a well-established anchor faculty to build intellectual capacity, increasing the number of PhD students in cardiometabolic health research, providing interdisciplinary research and leadership training to postdoctoral fellows and junior faculty, and increasing the number of health professional faculty involved in cardiovascular health research. To achieve our goal, there are 4 priority activities. Priority Activity 1 is to develop a bachelors to masters to PhD pathway program. We will develop graduate curriculum and establish a new PhD training graduate concentration in cardiometabolic health research. Priority Activity 2 is to hire a Senior Magnet Cardiovascular Scientist and Junior Scientist to build a corpus of researchers. Priority Activity 3 is to establish an annual Presidents Seminar to bring accomplished, nationally recognized prominent researchers on the Meharry campus to present and to engage with our PhD candidates and faculty for new networking and mentoring opportunities. Priority Activity 4 is to invest in research infrastructure to advance technological innovation on our campus for experimentation, data collection, and translational research focused on cardiometabolic disease. With endowment funds secured through the S21 mechanism, we will provide robust training opportunities to encourage more participation in health research focused on cardiometabolic diseases. The impact will be the establishment of a sustainable program that includes cardiometabolic health curricula for graduate students and a critical corpus of health researchers with active research projects in the area focused on cardiometabolic health. We will create a scholarly environment for teaching and research excellence in cardiometabolic health.

Public health relevance
PUBLIC HEALTH RELEVANCE SECTION Project Narrative The long-term objective of the Endowment for Cardiometabolic Health Research is to expand the capacity of Meharry Medical College (MMC) to enhance research and research training in cardiometabolic health. The program will address gaps in cardiometabolic health research. This will be accomplished by recruiting and developing new research faculty, establishing a new PhD program in cardiometabolic health research, and promoting research infrastructure.